Dissecting Neural Control of Panic-Related Behaviors

Project Summary/Abstract
Millions of Americans suffer from panic disorder, which is characterized by spontaneous and unexpected
occurrences of panic attacks. Patients experiencing panic attacks repeatedly report a persistent and prompt
urge to flee despite being in a safe, non-threatening environment such as the patient's home. However, the
underlying mechanisms of panic are unknown and treatments are often ineffective. Panic is commonly
modelled by escape elicited by imminent threats in rodents. Accordingly, escape-inducing circuits in mice
induce panic in humans. Indeed, electrical stimulation of the dorsal periaqueductal grey (dPAG) induces panic
in humans and escape in rodents. However, it is unknown how input from other regions to the dPAG modulate
panic-related escape. The dorsal premammillary nucleus (PMd) is the largest input to the panicogenic dPAG,
suggesting the PMd may have an important role in panic. However, the function of the PMd remains unknown.
We now show PMd activation induces hallmark panic-related phenotypes, including escape and tachycardia.
We hypothesize the PMd-dPAG projection is critical for enabling panic-related escape from threats. We
developed a novel assay that exposes mice to a live predator (a rat) in close proximity without a separating
barrier to induce naturalistic panic-related escape. In Aim 1, I will optogenetically activate and inhibit the PMd-
dPAG projection to test if activity in this circuit is, respectively, sufficient and necessary for panic-related
escape. In Aim 2, I propose to record PMd activity during exposure to a live predator to observe if increased
PMd activity measured by fiber photometry predicts escape and possibly other defensive behaviors. Finally, in
Aim 3, since our preliminary data show that dPAG neuronal activity correlates with panic-related escape, I will
inhibit upstream PMd activity while performing in vivo calcium imaging in the dPAG to test if PMd input is
necessary for accurate dPAG population encoding of escape. These Aims will be the first to demonstrate that
the PMd is a key, but previously unrecognized, node in the panic network that may be a potential target for
future panicolytic therapies. With the support of sponsoring and collaborating faculty from the Departments of
Psychology, Neurology, and Electrical Engineering at the University of California, Los Angeles, execution of
these Aims will provide advanced technical training on several sophisticated, cutting-edge techniques that
enable the perturbation and monitoring of neural circuitry. Furthermore, the proposed training plan, carefully
conceived by the sponsoring faculty, identifies several key Intellectual and Professional goals and concrete
benchmarks that will form the foundation for a well-rounded, comprehensive scientific training and successful
research career.

Public health relevance
Project Narrative Promptly fleeing from danger is an intense, metabolically consuming, and psychologically overwhelming response that is crucial for ensuring survival. In humans, these reactions can occur in the absence of threat, contributing to high prevalence of panic disorder. As the neural circuitry underlying panic disorder is not well- understood, these experiments propose to dissect how a novel, uncharacterized brain circuit from the dorsal premammillary nucleus to the dorsal periaqueductal grey may control extreme panic-related escape responses, leading to a better understanding of the pathogenic basis of panic.